Stanford Breast Metastasis Center Administrative Core

Abstract/Project Summary
The Stanford Breast Metastasis Center (SBMC) Administrative Core will operate by upholding the principle that
our success relies on a well coordinated and focused multidisciplinary team executing premier research. Our
core team has an established track record of working on large scale projects with scientific investigators from
multiple fields, including cancer biology, immunology, functional genomics, computational biology, bioinformatics
and statistics, breast medical oncology, pathology, surgery. Through our Administrative Core, we will provide
oversight that identifies and responds to short-term and long-term needs by executing three aims. Our first aim
is to establish and maintain an effective and responsive organizational structure that provides proper
communication and coordination of activities within the NCI Metastasis Network. For internal oversight, we will
convene an Executive Committee, including patient advocates, External Advisory Committee, Internal Advisory
Committee, and Steering Committee that will meet regularly to review current progress, make recommendations
and monitor future progress. All SBMC investigators and staff will be expected to attend bi-weekly SBMC
meetings where we will have general announcements by PIs, Project Leads and Core Leads, review our
milestones, hear updates and an in-depth presentation from one of our investigators followed by discussion. We
will maintain updated mailing lists and a website to disseminate announcements, archive summary notes from
meetings, host a calendar of activities and provide links to data and model repositories. Our second aim is to
establish and maintain a communication and logistics strategy for transparent and responsive interactions within
the SBMC the NCI MetNet and the broader scientific community. To foster exchange of data and methods within
other centers comprising the MetNet, we will actively participate in annual MetNet investigator meetings and
contribute to the activities of the MetNet by organizing and participating in collaborative activities and working
groups. Our third aim is to facilitate the evaluation of Center interim milestones and, if needed, implement
processes to revise milestones with NCI MetNet Program Manager approval. We will monitor progress at bi-
weekly SBMC team meetings through our SBMC Milestones Dashboard, which will summarize progress in our
three Projects and Cores. We will also report progress on milestones at NCI MetNet annual meeting. Thirdly, we
will host an onsite evaluation of our Center’s performance during annual NCI Site Reviews. Finally, in the unlikely
event that we experience a delay in meeting our milestones, we will engage a resolution strategy that will involve
our team and Steering Committee, and, as needed, the EAC, IAC, colleagues in other MetNet Centers and the
NCI.